Project 1: Transgenic TCR-mediated tumor therapy

Summary – Project 1
Merkel cell carcinoma (MCC) is a highly aggressive skin cancer diagnosed in >2,500 persons per year in
the US. ~80% of MCCs are caused by the Merkel cell polyomavirus (MCPyV), and these tumors rely on
persistently-expressed cell cycle promoting oncoproteins (T-Antigens). These viral T antigens are ideal targets
for immunotherapies: they are highly expressed, not readily lost, exclusive to tumor tissue, non-human in
sequence (reducing off-target risk), and highly immunogenic. Recent studies have shown that reducing
dysfunction of endogenous T cells in MCC is effective, as half of patients have durable responses to PD-1 axis
blockade. However, many patients do not respond, representing an unmet clinical need. We hypothesize that
patients whose tumors do not respond to PD-1 blockade have insufficient or poorly avid MCPyV-responsive T
cells, and that therapeutic efficacy can be improved with a combination of approaches.
In an R01-funded trial, we have used “Triple Therapy” to treat MCC patients with metastatic disease, where
we combined single-fraction radiation to reverse MCC-specific downregulation of MHC class I, infusion of
autologous ex vivo-expanded MCPyV specific CD8+ T cells to supplement the lack of effective MCPyV-specific
T cells and avelumab (a PD-L1 checkpoint inhibitor) to boost antigen-specific responses. These treatments
have been well tolerated, encouragingly effective (with 3 of 6 patients achieving complete remission, 2 durable
at >2 years), and we have demonstrated persistence, function, and tumor localization of infused T cells.
However, this strategy was limited by the rarity and low avidity of the endogenous MCPyV-specific T cells in
most patients, and the 2-3 months required to generate T cell products in the face of rapidly progressive
disease.
To circumvent the challenges encountered, we now propose a transgenic T cell therapy approach. We will 1)
use a newly developed high-throughput strategy to identify safe, high-affinity HLA-restricted T cell receptors
(TCRs) to ensure all patients can receive highly avid, effective MCPyV-specific T cells. We have successfully
used this approach to identify an MCPyV-specific HLA A*0201-restricted TCR (TCRA2-MCC1) and will now
employ these strategies to identify TCRs of 3 additional specificities. 2) in a Phase I/II trial for patients with PD-
1 blockade-refractory metastatic MCC, evaluate the safety and efficacy of autologous CD8+ T cells transduced
to express the validated TCRA2-MCC1 combined with MHC upregulation and PD-1 axis blockade, and 3) use a
suite of cutting-edge tools on patient samples to characterize infused T cells, MCC cells and other features of
the tumor microenvironment, identify parameters associated with treatment responses and/or failures. We
believe the proposed studies will provide critical insights into the design of next-generation T cell therapies for
MCC patients, with implications for other immunogenic malignancies.

Public health relevance
Narrative - Project 1 Merkel cell carcinoma (MCC) is an often-deadly skin cancer that is typically caused by a virus, and as such is an ideal model for the development of T cell immunotherapy approaches. Based on a high-throughput, broadly-applicable strategy to identify safe, highly active, tumor-specific T cell receptors (TCRs) we developed, we will identify clinical-grade MCC-specific TCRs and treat 16 patients in a Phase I/II trial. Cutting edge laboratory studies on serial blood and tumor biopsies obtained from patients will elucidate the reasons for success and/or failure of this approach, to better refine future therapies for MCC patients and broaden findings to patients with other malignancies.